A COMPARISON OF TWO STRAINS OF E COLI TO PRODUCE SEPTIC SHOCK IN DOGS

While live bacteria commonly cause infection, the relative roles of bacterial toxins versus live bacteria to produce morbidity and mortality are not known. If bacterial toxins are important factors, therapies directed at these toxins may be required. Even if no bacteria remain alive or grow, these preformed toxins may be important in determining morbidity and mortality. Therapies directed at these toxins may be important additions to antibiotic therapy.Using two E. coli, nonvirulent E. coli (086;H8) and a virulent E. coli (06;H1;K2), in the canine model, we designed a study to determine whether organism virulence factors or bacterial toxins were more important in producing septic shock. Measures of hemodynamic shock, blood cultures, endotoxin levels, and survival were done serially with both organisms live, both organisms killed, and with purified endotoxin from these organisms. Preliminary results from these studies have been presented at the American Federation of Clinical Research and the Society of Critical Care Medicine. These data suggested virulence factors are much more important than preformed endotoxins on development of endotoxemia.To further address this issue, we are collaborating with Tom Russo of LCI, NIAID, and more recently the University of Buffalo, to examine the role of endotoxin as a virulence factor within the same strain of E. coli. We are using a gene disruption technique to produce an E. coli strain with a deficiency in endotoxin O-type side chains (another virulence factor). This will further explore the relative role of endotoxin in septic shock. Much work is presently being done to target this pathogen in human septic shock. There has been much interest in these data because determination of the factors that produce morbidity in infection will guide trials for future therapies of children and adults with septic shock.